Administrative and Clinical Research Support Core

The administrative core will provide essential support for all administrative activities associated with the program project grant or al| Project and Cores. The administrative core will provide support for accounting, budgeting, fiscal reporting, protocol submission, dissemination of information between program sites, as well as preparation and distribution of protocol revisions and yearly renewal reporting. Protocol monitoring, data coordination, and communication among project and core key personnel through in-person meetings, regularly scheduled conference calls, and additional telephone communication will be the responsibility of the administrative core. Additionally, the core will support scheduling and coordination of internal research meetings and external consultant visits. The Core with centrally coordinate sample and clinical materials distribution between Projects, participating clinical sites and Cores. The Core will also support clinical trials by coordination of research nurse support at the University site for the therapeutic trials in Projects 2 and 3 and the prospective trials in Project 3.

Public health relevance
RELEVANCE (See instructions): The administrative and clinical support core will function to make the group cohesive and integrated. This will be accomplished by promoting communication, external review ofthe program, central data collection and i safety monitoring and sample dissemination.